Methionine Adenosyltransferase Alpha1 in Alcoholic Liver Disease

ABSTRACT
Methionine adenosyltransferase (MAT) is an essential cellular enzyme that catalyzes the formation of S-
adenosylmethionine (SAMe), the principal biological methyl donor and in liver, precursor of the key antioxidant
glutathione (GSH). In mammals, two different genes, MAT1A and MAT2A, encode for two homologous MAT
catalytic subunits, α1 and α2, respectively. MAT1A is primarily expressed in normal liver. Majority of patients
with chronic liver disease have decreased expression and activity of MAT1A-encoded isoenzymes. We found
MAT1A expression and hepatic SAMe levels are reduced in alcoholic hepatitis patients. While MAT
isoenzymes are widely acknowledged for catalyzing cytosolic SAMe biosynthesis, our recent works have
uncovered highly novel aspects of their functions. In addition to cytosol and nucleus, our preliminary data
indicate MATα1 is also present in the mitochondrial matrix to regulate mitochondrial function. This is important
as we found hepatocytes lack the mitochondrial SAMe transporter SLC25A26. Using immunoprecipitation (IP)
followed by mass spectrometry, we have identified many mitochondrial proteins and cytochrome P450 2E1
(CYP2E1) as MATα1-interacting proteins. Our preliminary data show that MATα1 negatively regulates
CYP2E1 expression mainly at the protein level via methylation, which has not been reported. Importantly,
MATα1 mitochondrial targeting is impaired in murine and human alcoholic liver disease (ALD) and we propose
two novel mechanisms that may cooperate in causing this impairment. The current proposal tests the central
hypothesis that MATα1 provides the SAMe source within the hepatocyte's mitochondrial matrix and
impairment in MATα1 mitochondrial targeting in ALD plays a key role in the pathogenesis of ALD. The
corollary hypothesis is that MATα1 maintains hepatocyte mitochondrial function in part by suppressing
CYP2E1 expression. Here we follow up these novel findings in three specific aims: 1) examine how MATα1
targets the mitochondria and why its targeting is impaired in ALD. We will elucidate how MATα1 targets
the mitochondria and mechanisms of its impaired targeting in ALD. We will test the novel hypothesis that this is
due to 1) increased MATα1 sumoylation and 2) increased interaction of MATα1 with PIN1 (a peptidyl-prolyl cis-
trans isomerase that recognizes a specific phosphorylated motif), 2) examine how MATα1 regulates CYP2E1
protein expression. We will examine how MATα1 regulates CYP2E1 protein stability at the molecular level
and identify CYP2E1 residues and interacting proteins that participate in this process, 3) examine the role of
mitochondrial MATα1 and MATα1-regulated CYP2E1 in ALD. We will test the novel hypothesis that
preventing MATα1 sumoylation or interaction with PIN1 will protect against reduced mitochondrial MATα1
content and injury in ALD. We will also examine whether MATα1 will protect against ALD by methylating
CYP2E1 at R379 to enhance its degradation. If successfully accomplished, these studies will change existing
paradigms on MATα1 biology, CYP2E1 regulation and may uncover druggable targets for ALD.

Public health relevance
PROJECT NARRATIVE Methionine adenosyltransferase (MAT) is an essential enzyme as it is responsible for the formation of S- adenosylmethionine, a key molecule that is required for normal cell function. Normal liver expresses mainly MAT1A and patients with chronic liver diseases including alcoholic liver disease have reduced expression of MAT1A. We have found that MAT1A protein is important for maintaining normal mitochondrial health in hepatocytes, the dominant cell type in the liver. In alcoholic liver disease, the level of this protein is reduced, which can result in mitochondrial dysfunction. The goals of this project are to understand how MAT1A protein gets into the mitochondria, why this is reduced in alcoholic liver disease and how this affects the expression of a key enzyme that is involved in the development of alcoholic liver injury. Successful completion of this project will not only improve our understanding of the role of MA1A in alcoholic liver injury, but may also uncover novel druggable targets.